Optimizing Treatment of Co-occurring Smoking and Unhealthy Alcohol use among PWH in Nairobi, Kenya

Project Summary.
Sub-Saharan Africa is home to >70% of people with HIV (PWH) globally. It is also burdened with rising rates of
tobacco use, high rates of unhealthy alcohol use, and high rates of tobacco and alcohol co-use. These
disparities are amplified in PWH in this region. Tobacco users drink more and alcohol users smoke more and
quit less than mono-users. Tobacco combines with alcohol to exert a destructive synergy expressed, in
particular, in extremely high rates of aerodigestive (especially esophageal) cancers. Kenya is the 7th most
populous country in Africa, with 54 million people, 1.6 million of whom are PWH. Tobacco and alcohol use
rates in Kenya, including Kenyan PWH, are higher than those in most sub-Saharan nations. Incidence rates of
esophageal cancer in Kenya are 2.9 times those of the US in men and 8.4 times those of the US in women.
There is an enormous need for better strategies to manage tobacco and alcohol co-use in Kenya and
throughout the world. Our group has been engaged in tobacco treatment research for PWH in Nairobi, Kenya
since 2018. We are completing a 2 x 2 factorial design randomized controlled trial (RCT) of Positively Smoke
Free intensive behavioral counseling ± bupropion, and we have collected detailed information on alcohol usage
in Kenyan PWH in the course of that study. We have created and piloted a new version of Positively Smoke
Free counseling to include content related to alcohol co-use and strategies to cut down or quit alcohol use.
Cytisine is a nicotinic acetylcholine receptor partial agonist that has been used for tobacco treatment since the
1960’s, mostly in Eastern Europe, Russia, and Canada. Multiple trials of cytisine, conducted almost exclusively
in White participants, have demonstrated that its efficacy in promoting smoking cessation is comparable to
varenicline, the first line tobacco treatment in the US. Cytisine is inexpensive, safe, and does not interact with
antiretroviral therapies. It is a potent treatment for alcohol dependence in animal models, but data to support its
use for this purpose in humans are scarce. There is virtually no published experience with cytisine on the
African continent, but Kenya’s Ministry of Health has expressed interest in this affordable agent if it is proven
effective in a Kenyan population. A placebo controlled trial of intensive counseling ± cytisine for Kenyan PWH
who smoke and drink alcohol heavily will advance the science of tobacco and alcohol co-use, it will strengthen
the case for cytisine use in Kenya and other low- and middle-income nations if effective, and it will address
significant health disparities in a resource-constrained area of the world. In this application to renew
1R01CA225419, we propose a 2 x 2 factorial RCT comparing Positively Smoke Free including alcohol-referent
content to standard care and comparing cytisine to placebo. We will study both tobacco and alcohol use
endpoints as primary and secondary outcomes. We will also examine putative mediators of intervention effects
on study outcomes. Finally, we will complete detailed cost analyses to estimate the cost-effectiveness of the
trial interventions in relation to the trial’s tobacco and alcohol use outcomes.

Public health relevance
Project Narrative. People with HIV (PWH) smoke tobacco cigarettes and drink alcohol at higher rates than the general population, both in the US and internationally, including low- and middle-income countries. Now that effective antiretroviral therapy is available throughout most of the world, PWH are surviving long enough to manifest the lethal consequences of both their smoking and drinking. In this project, we aim to advance the knowledge and understanding of treatment strategies (i.e. individual intensive counseling ± pharmacotherapy with cytisine) that target both tobacco and alcohol use among PWH in Kenya, a resource constrained environment, and to generate outcome data that may benefit co-users of tobacco and alcohol throughout the world.